Potent and Affordable GD2-Specific CAR T Cell Therapy for Glioblastoma Treatment Using Biomaterials

PROJECT SUMMARY
Glioblastoma is the most common primary brain malignancy in adults yet has no cure. Patients typically only live
12-15 months after treatment, with a five-year survival rate of less than 10%. Despite the poor patient outcomes,
only three new treatments have been approved for glioblastoma since 2005: temozolomide, bevacizumab, and
tumor-treating fields. The most common treatment method is maximal surgical resection followed by radiotherapy
or chemotherapy, but the highly progressive and recurrent nature of the disease causes treatment to be
ineffective. Chimeric antigen receptor (CAR) T cell therapy has emerged as a successful anti-cancer
immunotherapy with significant impact in treating blood cancers. There have been six FDA approved CAR T
cells therapies since 2017, demonstrating its clinical relevance. Unfortunately, typical CAR T cell production is a
complex and expensive process involving harvesting the patient’s blood, isolating the T cells, transferring the
CAR gene, extensive ex vivo expansion, and finally infusion of the expanded CAR T cells back into the patient.
This process costs around $500,000 per dose and can take over 20 days to complete. It is often used as a last
resort, causing many patients to succumb to their disease before receiving treatment. In addition, the lengthy ex
vivo expansion deteriorates T cell quality as it encourages T cell differentiation. It has been clinically shown that
having less-differentiated naïve/stem-like and central memory phenotypes after infusion is directly related to
patient outcomes due to the enhanced persistence of these phenotypes compared to effector phenotypes. The
goal of this project is to reduce the CAR T cell manufacturing time to three days and improve the quality and
potency of CAR T cells by using biomaterials to manufacture CAR T cells in vivo. These scaffolds will be used
to manufacture CAR T cells against GD2, a tumor-associated antigen overexpressed on glioma cells but limitedly
expressed on adjacent healthy cells. Limiting ex vivo manufacturing will reduce CAR T cell differentiation for
enhanced CAR T cell quality and persistence to improve therapeutic efficacy. For Aim 1, in vitro studies will
determine how CAR T cells are released from the scaffold over time and the phenotype of released cells. In vitro
coculture experiments with scaffold-produced CAR T cells and glioma cells will be performed to evaluate tumor
killing ability and secretion of proinflammatory cytokines. For Aim 2, an in vivo patient-derived orthotopic
xenograft model will be used to determine anti-tumor efficacy and survival in mice treated with biomaterial-
generated CAR T cells. In vivo CAR T cell phenotype and persistence will be evaluated in the blood, brain, bone
marrow, and spleen. This project will have a profound impact on glioblastoma treatment by demonstrating the
potential for biomaterials to provide sustained local delivery of less-differentiated CAR T cells, show enhanced
efficacy, and prevent disease relapse, which are highly important factors for clinical success in GBM patients.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Glioblastoma is an aggressive brain cancer with poor patient outcomes and no cure. CAR T cell therapy presents an opportunity to effectively treat glioblastoma but the highly expensive and time-consuming ex vivo manufacturing process deteriorates CAR T cell quality. This project aims to manufacture CAR T cells in vivo using biomaterial scaffolds to reduce the manufacturing time to just three days and produce high-quality CAR T cells that are more potent, making the therapy more affordable and improving CAR T cell persistence and therapeutic efficacy for glioblastoma patients.